Physiology and Organization of Retinal Cell Types

Project Abstract
Neurons in the vertebrate retina are classified into well-defined types and organized in a layered structure
according to a set of organizational principles. In the mammalian retina, the dendritic and axonal processes of
second- and third-order neurons are strategically positioned to utilize the conventional ON and OFF segregation
of the inner plexiform layer (IPL). However, cell types that ramify in the distal margin of the IPL, known as the
accessory ON layer (AOL), often exhibit paradoxical ON responses that require anatomical and physiological
explanation. Recently, we discovered a new group of bipolar cell populations that co-stratify with M1
photoreceptive ganglion cells and dopaminergic amacrine cells (DACs) in the AOL and display ON light
responses. The goal of this proposal is to understand the organization and function of these noncanonical bipolar
cells (NBCs) in the retina. To achieve this, we have developed an innovative experimental approach that
integrates advanced electrophysiological recordings with two-photon Ca and glutamate imaging of genetically
labeled neurons in a powerful wholemount retinal preparation. This functional approach is further enhanced by
ultrastructural reconstructions of NBC synaptic circuitry using serial block EM connectomics. There are three
specific aims: (1) Understand the physiological responses and anatomical properties of NBCs in the mouse
retina, (2) Understand the synaptic physiology of glutamate signaling in the accessory ON layer (AOL), (3)
Connectomic and functional characterization of NBC synaptic circuits. Results from this study are expected to
provide new insights into the function and organization of NBCs in the AOL and their interactions with other
retinal neurons.

Public health relevance
Project Narrative Bipolar cells are critical interneurons in the retina, which relay visual information from photoreceptors in the outer retina to output neurons in the inner retina. This proposal is to study new non-canonical bipolar cell types that challenge some of the fundamental theories about mammalian retinal organization. Knowledge gained from this study will help us understand retinal structure and function in health and disease.